The Pathophysiological Role of Cerebellar Glia in Rett Syndrome

PROJECT SUMMARY/ABSTRACT
Rett syndrome (RTT) is the leading cause of severe intellectual disability in girls and women. Individuals with
RTT develop typically until 6-­18 months, when autism-­like behaviors and deficits in purposeful hand use and
speech start to develop. Loss-­of-­function mutations in the transcriptional regulator methyl-­CpG-­binding protein
2 (MECP2) occur in >95% of RTT cases. Initially, researchers regarded MeCP2 deficiency in neurons as the
exclusive cause of RTT. However, recent studies have revealed that glia have a pathological role in RTT
etiology. Studies have not yet uncovered the underlying cellular mechanisms of glial cell dysfunction in Mecp2
rodent models or the impact of this dysfunction on brain function. In this study, we propose to examine the
contribution of a specific glial subtype, Bergmann glia cells (BGs) in the cerebellum, to the motor and social
deficits in RTT. We will focus on BGs because (1) cerebellar disruption likely contributes to the motor and
social deficits in RTT and (2) BGs are the major glial subtype in the cerebellum. We propose to characterize
cerebellar function in conditional knockout (cKO) mice that lack Mecp2 in BGs using a repertoire of
approaches, including intracellular whole-­cell recordings, in vivo recordings of single units and local field
potentials, in vivo and ex vivo imaging of genetically-­encoded Ca2+, glutamate, and dopamine (DA) sensors
(GCaMP7, iGluSnFr, and dLight1.1, respectively), optogenetics, chemogenetics, near super-­resolution
confocal microscopy, and behavioral assessments using unbiased machine-­learning approaches. Our
preliminary results indicate deficits in BGs from Mecp2-­deficient mice, including higher expression levels of the
GluA1 subunit of AMPA receptors (AMPARs), and depolarized membrane potentials. In addition, we have
preliminary evidence of DAergic modulation of BGs through the activation of D1 receptors (D1Rs) activated by
either electrical or optogenetic stimulation of DAergic inputs to the cerebellum. Of high relevance to motor and
social symptoms in RTT, the expression levels of D1Rs, which modulate GluA1 surface insertion, are higher in
Mecp2 KO mice. We hypothesize that BGs in the cerebellum have a pathophysiological role in motor and
social deficits in Mecp2-­deficient mice. We propose two Aims: (1) Define cerebellar BG dysfunction in Mecp2
cKO mice;; (2) Characterize DAergic modulation of cerebellar BGs in Mecp2 cKO mice. The proposed studies
will elucidate the consequences of impaired DAergic modulation of astrocyte function on cerebellar-­dependent
behaviors, which will have broad implications not only for RTT but also for other brain disorders associated
with cerebellar dysfunction.

Public health relevance
PROJECT NARRATIVE Rett syndrome (RTT), caused by MECP2 mutations, presents with stereotypic hand movements, ambulatory difficulties, and social impairments. Dysfunctional interactions between glial cells and neurons and their modulation by dopamine may play crucial pathological roles in developing neurological symptoms. In this proposal, we investigate these mechanisms in the cerebellum at the molecular, cellular, and behavioral levels using a combination of state-of-the-art approaches.